Cell type-specific complement activation and glial reactivity in male and female mice with dietary obesity

PROJECT SUMMARY
Neuroinflammation is a shared feature of obesity and dementia, but the processes that initiate and perpetuate
glial reactivity are not well understood,. Several recent studies, including from our lab, have outlined signaling
cascades linking peripheral and central inflammation in obesity in males, but vulnerability to obesity-induced
metabolic pathology is sexually dimorphic, and susceptibility to neuroinflammation follows similar patterns. Adult
females exhibit stronger innate immunity, and evidence from clinical and experimental studies suggests that this
dimorphism involves sex differences in activation of complement. However, current understanding of tissue-
specific complement activation remains rudimentary due to the scarcity of approaches for cell type-specific
manipulation. To this end, we generated transgenic mice with inducible, cell type-specific deletion of the
endogenous complement inhibitor Crry, and will use this model to distinguish between target cells and 'bystander'
populations in the adult brain. After determining whether selective activation of complement is sufficient for
neuroinflammation, we will examine the role of sexually dimorphic complement activation as a mechanism for
differential vulnerability to synaptic and behavioral dysfunction on obesogenic diets. These themes will be
addressed using state-of-the-art methodology, including newly developed strategies for high-throughput
morphometric analysis of glial cells in cleared brains and region-specific manipulation of glial gene expression.

Public health relevance
PROJECT NARRATIVE Males and females differ with respect to complement-mediated innate immunity and susceptibility to obesity- induced pathophysiology in multiple tissues, including the brain. These experiments will determine whether sexually dimorphic regulation of complement underlies differential vulnerability to neuroinflammation in mice with dietary obesity. We will use state-of-the-art methodology, including machine learning-based reconstruction of glia in cleared brains, to generate a comprehensive topographical map of neuroimmune responses to chronic overnutrition and elucidate the role of complement in these effects.